Sleep and affective disturbances in the etiology of Alzheimer's disease

Parent R01 Project Summary / Abstract
Provided on first page of Research Strategy as required per the FOA.

Public health relevance
Project Narrative This diversity supplement to R01 NIA R01AG070841 will provide funding for UI postdoctoral scholar Dr. Louis Kolling to conduct research as part of the parent grant focusing on the etiology of early Alzheimer’s disease. It also provides funding for professional development and travel expenses for the candidate.